Swallowable smart capsule for targeted gastrointestinal microbiome sampling

PROJECT SUMMARY/ABSTRACT
The human gastrointestinal (GI) tract hosts the largest number of bacterial species found in the body, often
referred to as the gut microbiota. This diverse and complex microbial community functionally expands the host
genome, critically impacting metabolism, physiology, nutrition, and immune function. Current methods for
assessing the human gut microbiota are based on fecal sampling, visualization, and various endoscopy-
assisted biopsy techniques. Endoscopy-assisted techniques are invasive and usually incapable of retrieving
samples from the small intestine. While stool samples provide noninvasive assessment, they are incapable of
preserving spatial and temporal information of the bacteria through the GI tract. Therefore, we propose to
develop an ingestible non-invasive smart sampling capsule (SSC)-based device that will provide a targeted
sampling of viable gut microbes. The developed technology would allow unique insights into the impact that
live microbes and other microbiota modulators have on the gut microbiota in hard-to-access GI regions.
In the R21 phase of the project, we will design and develop two SSCs that provide targeted sampling in the
small or large intestines, respectively. These SSCs are composed of acrylic casing that will house an
absorbent hydrogel and a gas permeable membrane, as well as a nonmagnetic tracer to detect the capsule’s
excretion in the feces. The hydrogel acts as a passive actuator such that upon swelling, it aspirates the
intestinal fluid with its containing microbiota and seals the capsule. Single-layer pH-triggered and double pH-
and microbial-triggered polymeric coatings will be utilized to delay the sampling until the capsule reaches the
proximal small or large intestine, respectively. During this phase, in-depth capsule performance (e.g. sampling
and retrievability) of the two SSCs will be assessed in vitro and in diet-controlled pigs. The R33 phase with two
aims will clinically assess the effects of a U.S.-style Healthy Eating Pattern with low- versus high-dietary fiber
content on segmental GI microbiota in humans using the two developed SSCs. We will first work to adapt the
SSC methodology from the animal model to human subjects. This proof-of-principle study will be conducted to
validate the effectiveness of SSC recovery from participants away from the testing facility. We will also assess
the targeted sampling performance of the SSCs at appropriate locations along the GI tract using an FDA-
approved large intestine-specific delivery drug (Balsalazide) as a testing control compound. For the clinical
study, we will use the two SSCs to assess and compare the effects of high- versus low-fiber U.S.-style Healthy
Eating Pattern on the gut microbiota in the proximal small and large intestine of 40 young, middle-aged, and
older adults. The overall goal of this R21/R33 project is to produce highly reliable, practical, and cost-effective
smart sampling capsules, suitable for use for research and clinical applications focused on GI function and
human health. Accomplishing this research will open new areas of microbiome research, enabling access to
previously hard-to-access regions of the gut, consistent with NIH interests, including precision nutrition.

Public health relevance
PROJECT NARRATIVE This high-risk, high-reward project will explore developing two battery-free smart capsules for targeted sampling of human microbiota from proximal small and large intestine regions. Animal and human studies, including two randomized, diet-controlled clinical trials in adults, will be used to assess performance of the capsules when sampling segmental gut microbiota. Importantly, gastrointestinal content collected by our smart capsules will contain microbes viable for in vitro cultivation.